Mapping the sequence-function landscape of a small reactive protein in ultra-high-throughput

Project Summary/Abstract
Understanding how a protein’s amino acid sequence controls biophysical properties like stability, folding, and
reactivity is key to designing better enzymes. However, this task remains challenging due to the complexity of
protein conformational ensembles and the scarcity of functional data across sequence space. As a result,
computational enzyme design is difficult, and most designed enzymes fail to function without clear indications
why. Large-scale experiments can help uncover how specific residues and higher-order interactions affect
function, offering the basis for improved computational models and better strategies for enzyme design.
However, most surveys of sequence space either cover relatively few variants, or sample only a very narrow
region of sequence space deeply. Combining high-throughput functional mapping with de novo design of new
enzymes has been out of reach due to the size and complexity of enzymes typically targeted in such
experiments. To this end, we propose to map the sequence-function landscape of SpyCatcher, a small
reactive protein that forms a covalent bond with its substrate SpyTag, investigating both natural and de novo
sequences. While not a true enzyme, SpyCatcher’s small size (80 residues) and simple reaction mechanism
make it a tractable minimal model for enzyme-like reactivity. In Aim 1, we will use cDNA display-based to
measure the reactivity, substrate binding kinetics, and stability of ~ 1 million natural SpyCatcher variants. The
unprecedented scale of these functional measurements on a uniquely simple system will allow us to rigorously
explore additive and non-additive sequence-function relationships and identify predictive patterns using
machine-learning models. In Aim 2, we will leverage de novo design to explore further reaches of sequence
space and test different design strategies in high-throughput, creating SpyCatcher-like proteins with sequences
far from natural ones. These designs (three rounds of ~500,000 sequences) will be assayed with the same
high-throughput assays to iteratively inform our design process and improve criteria for designing proteins with
functional reactivity. We aim to generate high-quality, large-scale datasets spanning both natural and
unnatural sequence space in order to uncover fundamental "rules" of reactive protein design, which
can inform future engineering efforts. By producing interpretable data that links sequence to biophysical
properties, we aim to enhance our ability to design proteins with tailored functions.

Public health relevance
Project Narrative Proteins are highly complex molecular machines, and designing custom proteins to solve problems in health and biotechnology is hindered by our limited understanding of how protein sequence encodes stability, substrate binding, and function. We propose to experimentally measure these properties for ~ one million natural and computationally designed variants of a simple reactive protein, and to use this unprecedented dataset to learn relationships between sequence and reactivity. Understanding the criteria connecting sequence to enzymatic function could open up new strategies in protein engineering.